Multimodal prediction of behavioral and mental health outcomes in incarcerated women

Project Summary/Abstract
Research in psychology and neuroscience has helped deepen our understanding of relationships
between mental health issues, social-environmental factors, and maladaptive behaviors
contributing to risk for incarceration. Such research holds significant economic implications, as
the societal cost of crime in the United States is a staggering $3.2 trillion annually, a sum that
exceeds annual expenditures across all national health care. While most of these costs are due
to men, incarcerated women represent the single fastest growing segment of the criminal legal
population over recent decades. Relative to men, women in the legal system display higher rates
of mental health problems, including with comorbid substance use, those of which result in a
multitude of negative outcomes that impact women and their overall psychosocial functioning, as
well as social networks and public health systems, broadly. Despite this, there has been little
modern research dedicated to female forensic populations. Indeed, we need prospective work in
forensic samples of women aimed at understanding adaptive and maladaptive changes in mental
health functioning over time, including risk and protective factors that influence these changes.
This type of work is far reaching, as it can be translated to treatment options to provide better
long-range outcomes for this population. In prior NIH-supported work, we have examined
psychosocial and brain functioning in 588 incarcerated women and female youth. Here we
propose to utilize this sample to create a unique longitudinal study in order to develop algorithms
that help predict mental health functioning and related outcomes (e.g., recidivism, substance use
relapse). Our algorithms will utilize the latest in machine learning techniques and will include
multimodal (psychosocial, forensic, and neuroimaging) variables. Utilizing these methods, we
intend to identify specific brain measures, in combination with psychosocial and forensic
variables, that accompany long-range outcomes of resilience (desistance) and risk (poor global
mental health, recidivism, substance use relapse). The translational value of this work will be to
clarify informative patterns of data that may indicate positive outcomes. Furthermore, neural
measures indicative of specific vulnerability will be identified as targets for treatment and novel
intervention strategies. By identifying vulnerabilities and the changes that accompany positive
outcomes, we will be closer to understanding ways to improve outcomes for vulnerable women.

Public health relevance
Project Narrative Despite growing rates of incarceration in women, as well as high prevalence of mental health problems in this population, little empirical attention has been dedicated to understanding factors that promote improvement in their mental health and functioning over time. This project employs multimodal methods to test ways in which psychosocial, forensic, and neuroimaging variables longitudinally interact to predict resilience and vulnerability associated with mental health and related outcomes in women. These methods will be used to better understand ways of promoting adaptive mental health and behavioral outcomes in this particularly vulnerable population.